Statistical methods and tools for cancer risk prediction in families with germline mutations in TP53

Project Summary
Sophisticated risk prediction modeling has greatly improved screening and testing for inheritable cancer
syndromes such as BRCA1/2 mutations in breast cancer. Such a quantitative risk prediction model is urgently
needed for the early detection of the Li-Fraumeni syndrome (LFS) following the demonstration of reduced
mortality with surveillance testing for that syndrome. LFS primarily arises from germline mutations in the TP53
tumor suppressor gene and is characterized by cancer occurring relatively early in life, often repeatedly over a
lifetime, and affecting multiple sites that overlap with those of other cancer syndromes, in particular the
hereditary breast and ovarian cancer syndrome. Our objective is to improve the clinical management of
individuals with a family history of early-onset cancers by developing mathematical models to assess 1)
germline mutation carrier probability prior to TP53 testing and 2) the absolute lifetime risk of developing
cancers in individuals with TP53 mutations. Our rationale is that our advanced models will enable the
systematic and comprehensive risk evaluation of families with inherited TP53 mutations so that genetic
counselors and physicians can provide more effective counseling and screening of individuals who carry TP53
germline mutations, given the high frequency and varied cancer-type outcomes in these individuals. We will
accomplish our research objective through the following Specific Aims. 1) Characterize the onset of specific
cancer types for individuals at risk of LFS: a) Estimate the penetrance of TP53 mutation-associated cancers by
cancer type, using extended-family data from MD Anderson Cancer Center (MDACC) and from external clinics;
b) Develop LFSPROCS to incorporate cancer-type-specific penetrances, and validate these models in
predicting future risk; c) Enrich LFSPRO with additional modifiers of cancer risk, such as HER2 status for
breast cancer; 2) Characterize the number of primary cancers for individuals at risk of LFS: a) estimate the
penetrance for the number of primary cancers using extended-family data; c) Develop LFSPROMP and
LFSPROMP+CS to incorporate new penetrances and validate these models; and 3) Develop software and
disseminate it among cancer genetic clinics. Our significant contribution will be to develop an advanced
quantitative risk assessment tool that will provide more accurate risk quantification, and to provide a general
statistical framework for including additional cancer sites and cancer genes for risk assessment in the future.
The associated software suite LFSPRO will be quickly disseminated into the MDACC Li-Fraumeni Education
and Early Detection (LEAD) screening program, as well as other screening studies in the nation. LFSPRO is
already integrated in BayesMendel and CancerGene packages, which are widely used for risk assessment and
counseling at high-risk cancer clinics, in particular breast cancer clinics. With the addition of our advanced
models, these software tools will continue to bring LFS counseling to new populations under clinical settings
and reach more families that are affected by TP53 mutations.

Public health relevance
Narrative: The proposed research is relevant to public health because it will provide personalized risk assessment for families that suffer from multiple primary and early-onset cancers that are caused by an inherited p53 mutation. This research will help with the current clinical practice and improve the early detection of a wide spectrum of early-onset cancers in cancer-prone individuals.